Effects of antifungal drug treatment and immune dysfunction on the evolutionary dynamics of gut-colonizing Candida glabrata

Invasive fungal infections are estimated to cause ~2.5 million deaths per year worldwide, constituting an
enormous health and economic burden. Many invasive fungal infections are opportunistic: fungi harmlessly
colonize mucosal surfaces, such as the gastrointestinal (GI) tract, in healthy individuals, but can cause life-
threatening systemic infections in those with immune dysfunction. Such infections are usually caused by the
individual’s own commensal strains and can be preceded by fungal expansions in the GI tract (e.g., due to the
use of antibiotics). The GI tract is also a key reservoir where drug-sensitive commensal populations produce
drug-resistant isolates, for which very few therapeutic options are available due to our limited antifungal drug
armamentarium. Thus, the host GI tract is a key fungal commensal niche whose population dynamics can have
dire clinical consequences. However, these dynamics are almost entirely unexplored either under normal
conditions, during antifungal drug treatment, or when gut mucosal immunity is impaired. Candida glabrata is a
major opportunistic fungal pathogen and a common human gut commensal fungus. C. glabrata infections are
challenging to cure, in part due to its widely documented propensity to rapidly evolve antifungal drug resistance.
We have used a mouse model of C. glabrata gut colonization to track the evolution of resistance to caspofungin
(CSF), one of the echinocandin class antifungal drugs. Using this model and amplicon and whole genome
sequencing, we showed that the evolution of CSF resistance is unexpectedly complex, with multiple small-effect
drug susceptibility-reducing mutations occurring rapidly and fluctuating until the emergence of a large-effect
mutation in the drug’s target gene (FKS2) conferring clinical resistance. This limited analysis using standard
genomic tools suggests that during antifungal drug treatment, gut-colonizing C. glabrata undergoes complex
population dynamics with clonal interference, which underlie the evolution of antifungal drug resistance. We
propose to perform an in-depth analysis of C. glabrata evolutionary dynamics in the host GI tract by using
barcode-enabled lineage tracking, a technique developed in the model fungus Saccharomyces cerevisiae
(closely related to C. glabrata) that has yielded many insights about its evolution in culture under different
stresses. We now have access to a collection of C. glabrata strains carrying hundreds of thousands of unique
DNA barcodes, which has been developed and validated in the lab of Dr. Gavin Sherlock, a pioneer of lineage
tracking technology. We propose to use this unique resource in our mouse gut colonization model to elucidate
the population and evolutionary dynamics of gut-colonizing C. glabrata during treatment with two different
echinocandins (CSF and micafungin, Aim 1) and under clinically-relevant conditions of immunodeficiency
(neutropenia, p47phox-/-, and CARD9-/-, Aim 2). The results will elucidate how antifungal drugs or immune
dysfunction influence the adaptation and evolution of gut-colonizing C. glabrata and may help develop improved
strategies of fungal control in the immunocompromised and reduce the emergence of drug-resistant mutants.

Public health relevance
Candida glabrata is an opportunistic fungal pathogen that poses a danger to immunocompromised individuals and rapidly evolves resistance to frontline antifungal agents, such as the echinocandins. C. glabrata is a natural human gut commensal, and the gut reservoir of C. glabrata is an important source of infecting and drug-resistant strains. We propose to use barcoded C. glabrata libraries in a murine gut colonization model to elucidate the evolutionary dynamics of gut-commensal C. glabrata during echinocandin treatment and in immunocompromised hosts.